Prescription Stimulant Supply Shocks: Assessing the Impacts on Health Outcomes and Disparities

Project Abstract
In the last decade, there has been an alarming number of prescription drug shortages, with over 100 ongoing
shortages each year in the U.S. These shortages may have negative consequences on patients and
providers; they can lead to decreased convenience, treatment interruption, less effective care, and, at an
extreme, death. The potential effects may be particularly magnified for vulnerable populations with chronic
mental health conditions. Yet, there is little rigorous evidence on the impacts of drug shortages on the health
of these vulnerable populations. This project will begin filling this gap by studying the impacts on youth with
attention-deficit hyperactivity disorder (ADHD) of a 2022 nationwide shortage in immediate-release
formulations of amphetamine mixed salts, a class of prescription stimulant medications including Adderall.
This shortage received substantial news coverage, with stakeholders voicing their concerns about the impact
on patients who can no longer get essential medications. Untreated ADHD may impact a wide variety of
short-term health (e.g., emergency department visits) and non-health (e.g., school disruptions) outcomes,
which could have significant consequences on the long-term trajectory of patients. To bring evidence to bear
on the impact of this shortage, using national data on amphetamine prescriptions as well as comprehensive
claims data from Allegheny County, PA, and Medicaid enrollees nationwide, we propose to 1) construct
community-level measures of the “amphetamine gap” and broader “stimulant gap,” and then assess their
relationships with community-level demographic, socioeconomic, and healthcare characteristics; 2) evaluate
whether youths in communities affected by the stimulant shortage experienced differential trends in overall
treatment for ADHD, mental health, and substance use disorders; 3) investigate treatment process, mental
health, substance use, and educational consequences for youth with ADHD whose treatment regimen may
have been interrupted by the shortage, and 4) determine whether there are disparate impacts of the shortage
based on patient race and ethnicity, urbanicity, prescriber specialty, and school/community characteristics. In
addition to furthering academic and health services research on the impact of drug shortages, the findings
from this study can help inform regulators on how to mitigate the impact of supply-side disruptions to
stimulants.

Public health relevance
PROJECT NARRATIVE This research will characterize the timing and magnitude of the recent stimulant shortage and assess its impacts on the mental and behavioral health outcomes of children and adolescents with attention-deficit hyperactivity disorder and their communities. Combining complementary data from household surveys, schools, and administrative healthcare claims, this project will evaluate the extent to which exposure to the prescription stimulant shortage exacerbated disparities in mental health treatment and outcomes, as well as the potential moderating role of school, healthcare system, and community factors in mitigating harms. Findings will help identify community- and individual-level factors that are associated with greater vulnerability to supply shocks, as well as inform policies and practices to protect against the public health and broader social costs associated with disruptions to prescription stimulant supply and access.